Functional Characterization of Genetic Variants in Rare Disease Associated with Shoc2 scaffold

Summary
Mutations in the Shoc2 gene result in a developmental disorder called Noonan syndrome with loose anagen
hair (NSLH), a condition affecting craniofacial features, the heart, the digestive system, and neural
development. The Shoc2 is essential for transmitting the ERK1/2 cascade signals that control the
morphogenesis of neural crest-derived tissues. Shoc2 forms intricate protein complexes to amplify intracellular
signals, regulate the distribution of signaling proteins, and control gene expression programs during cell
lineage specification. This application is led by the notion that functional analyses of different Shoc2 variants of
unknown significance identified in patients with birth defects will give important insights into the mechanisms by
which these pathogenic variants affect cell differentiation and how these alterations lead to the variety of
phenotypes observed in NSLH patients. We will use a zebrafish vertebrate model carrying patient variants to
gain insights into the molecular and cellular processes altered by Shoc2 variants in neural crest-derived
lineages. This study will also examine how these variants impact Shoc2's function by dissecting its interactions
with other proteins and its localization within cells using biochemical and biophysical approaches. Results from
this work will fill an essential gap in our understanding of the fundamental principles by which alterations of
different aspects of signal transmission result in human disease with variable phenotypic outcomes. This work
will also have a broader impact on elucidating the importance of cell signaling mechanisms in craniofacial
morphogenesis.

Public health relevance
Public Health Relevance Statement Rare diseases collectively affect approximately 25-30 million people in the United States and disproportionally affect children. The proposed work will result in a novel vertebrate model, insights into the pathogenesis of the rare developmental disorder associated with Shoc2 variants and paraments to assess the pathogenicity of genetic variants associated with birth defects. Ultimately, this work will provide a model for the future development of guidelines for the diagnosis and treatment of rare disease.